A randomized trial of a video-based family intervention for home visited mothers with perinatal depressive symptoms

PROJECT SUMMARY
The Maternal, Infant, and Early Childhood Home Visiting Program is a national child abuse prevention
strategy that facilitates evidence-based home visiting for vulnerable families throughout the U.S. Mothers
(pregnant and postpartum) with clinically significant depressive symptoms make up a significant portion of
home visited clients. These mothers experience family conflict that precipitates and exacerbates their
depressive symptoms. They infrequently get treatment due to multiple barriers that are compounded for those
who live in rural areas. The proposed study addresses a critical service need for home visited mothers with
moderate to severe depressive symptoms, including those with co-occurring moderate to severe anxiety
symptoms, in rural areas with low access to treatment. The proposed study builds on the success of our NIMH-
funded R34 that assessed the feasibility, acceptability, safety, tolerability and preliminary effectiveness of an
innovative video-based family therapy intervention (Resilience Enhancement Skills Training, REST) for home
visited mothers with moderate to severe depressive symptoms and moderate to high family conflict. Our R01
application aligns with NIMH’s high priority area (NOT-MH-21-270) to test the effectiveness of REST
compared to standard of care (Video-based Problem Solving individual Therapy, V-PST) for treatment of home
visited mothers with moderate to severe depressive symptoms, including those with co-occurring moderate to
severe anxiety symptoms, and moderate to high family conflict. The proposed study uses an effectiveness-
implementation hybrid type 1 design with a randomized trial and includes three Specific Aims: 1) Determine
REST’s sustained impacts on outcomes (family conflict, family cohesion, maternal depressive symptom
severity, co-occurring maternal anxiety symptom severity, and maternal job attainment/school enrollment) at
post-intervention, 3-month, 6-month, 12-month, and 18-month follow-ups; 2) Identify family-level
mechanisms of change on treatment response at 12-month and 18-month follow-ups; and 3) Investigate
implementation strategies preferred by home visiting agency affiliated therapists to sustain high fidelity to
REST. Successful completion of the aims is the initial step to accomplish our long-term goal to disseminate
REST to home visiting agency affiliated therapists who serve home visited families in rural regions of the U.S.

Public health relevance
Project Narrative The Maternal, Infant, and Early Childhood Home Visiting Program facilitates evidence-based home visiting for vulnerable families throughout the U.S. Mothers (pregnant and postpartum) with clinically significant depressive symptoms make up a significant portion of home visited clients and family conflict increases the severity of their depressive symptoms. The proposed study builds on our NIMH-funded R34 that assessed the feasibility, acceptability, safety, tolerability and preliminary effectiveness of an innovative video-based family therapy intervention (Resilience Enhancement Skills Training, REST) for home visited mothers with moderate to severe depressive symptoms and moderate to high conflict with their family members. The proposed study uses an effectiveness-implementation hybrid type 1 design with a randomized trial to compare REST to standard of care (Video-based Problem Solving individual Therapy, V-PST) in a larger sample of home visited families and extend the follow-up to 18 months to test sustained impacts on reducing family conflict, increasing family cohesion, reducing maternal depressive symptom severity and co-occurring maternal anxiety symptom severity, and increasing maternal job attainment/school enrollment.